IMPACCT: Infrastructure for Musculoskeletal Pediatric Acute Care Clinical Trials

ABSTRACT
The management of two common upper extremity injuries, pediatric medial epicondyle fractures (MEF)
and displaced distal radius fractures (DRF), is controversial with high practice variation. The debate largely
focusses on whether to reduce these injuries to restore their usual position or to allow the fractures to heal in
their injured position with simple immobilization. Observational studies support both reduction and simple
immobilization for MEF and DRF. In both injuries, there have been few prospective and no randomized studies
evaluating their treatment. Given the widespread variation in practice, children are either undergoing
unnecessary procedures and anesthetic events when surgeons opt for reduction under anesthesia/ conscious
sedation OR are being undertreated by simple immobilization. Both scenarios are unacceptable in that children
face either anesthetic risks and extra costs or poor alignment with potential long term functional disability
To address such clinical dilemmas, the Infrastructure for Musculoskeletal Pediatric Acute Care Clinical
Trials (IMPACCT) consortium was organized to develop the infrastructure and experience necessary for
multicenter randomized clinical trials. IMPACCT’s leadership has expertise in leading multicenter clinical trials
and its members represent 32 diverse centers from the Pediatric Orthopaedic Society of North America
(POSNA). During the IMPACCT Consensus Conference, participants agreed that that MEF and DRF have the
equipoise necessary and are the most pressing clinical controversies. A similar priority-setting study from the
United Kingdom identified these questions as important controversies in children’s orthopaedic surgery.
POSNA-wide surveys confirmed MEF and DRF treatment variation and surgeons’ willingness to randomize.
A multicenter randomized superiority trial of children with MEF and DRF is required to evaluate the
clinical effectiveness of reduction under anesthesia/sedation vs. simple immobilization. The central hypothesis
of this proposal is that children treated with reduction under general anesthesia (MEF) or conscious sedation
(DRF) will have higher patient reported outcome scores compared to those treated with simple immobilization
alone. Trials on both fractures will be conducted simultaneously to take advantage of the economy of scale and
are similar in terms of anatomic location, outcome measures, and whether an intervention is necessary. Thirty-
one sites have agreed to recruit, randomize and treat a total of 688 patients according to the pragmatic
protocols. Investigators have partnered with the Trial Innovation Network to increase the efficiency of trial
development and execution. NIAMS has awarded this initiative an R34 Clinical Trials Planning Grant. This
proposal will support the active study phase when patients are recruited, treated, and followed and when
results are analyzed and disseminated.
The completion of these trials will provide a framework, infrastructure and experience for future
prospective multicenter clinical trials in pediatric orthopaedics as its results guide clinical decision-making.

Public health relevance
PROJECT NARRATIVE Pediatric medial epicondyle fractures (MEF) and displaced distal radius fractures (DRF) are two common injuries which lack consensus and adequate evidence to guide clinical decision making. Children are either unnecessarily undergoing costly procedures with added risks OR are being undertreated if their bone is not reduced to its original place which may result in long term disability. This grant will enable us to simultaneously compare simple immobilization to reduction for MEF and DRF through multicenter, randomized controlled trials using patient reported outcomes.